Blood-Based Testing for Advanced Adenoma

PROJECT SUMMARY/ABSTRACT
The goal of our Clinical Validation Center (CVC) is to advance and validate blood-based detection of colorectal
advanced adenoma. Whereas blood-based testing for invasive colorectal cancer is progressing, with multiple
companies pursuing products, the ability of blood-based testing to detect advanced adenomas, the pre-
malignant lesions closest to invasive cancer, is uncertain. To optimally impact colorectal cancer incidence,
blood-based biomarkers cannot just detect cancer, they should also have sufficient sensitivity to identify
subjects with advanced adenomas. For our CVC, we organized and assembled a network of highly skilled
clinical centers including a focus on minority populations, to prospectively collect well-characterized, high-
quality blood specimens from a large number of subjects with advanced adenoma prior to undergoing
polypectomy and serially post-polypectomy. From the same clinical centers, we will collect blood specimens
from control subjects. Specimens will be collected and processed using standard protocols, and relevant
demographic and clinical variables will be captured to facilitate biomarker validation studies. Specifically, we
will use these well-characterized specimens to validate our data on the utility of original, innovative techniques
for molecular detection of advanced adenomas including RealSeqS in combination with custom machine
learning algorithms such as SignaL. We propose two Specific Aims. In Specific Aim 1, we will conduct a phase
2 case-control study to validate our novel methods for advanced adenoma detection. We will prospectively
recruit patients with advanced adenoma (N=400) and site-specific control subjects (N=400) for comparison to
the case subjects. In Specific Aim 2, we will utilize serial blood specimens systematically collected post-
polypectomy from our case subjects to determine whether our novel molecular detection techniques can be
used to predict likelihood of recurrence and potentially guide surveillance colonoscopy exams. Advanced
adenomas are the important, next frontier in non-invasive colorectal cancer screening, and our CVC is
equipped to profoundly advance blood-based detection of advanced adenoma.

Public health relevance
PROJECT NARRATIVE The objective of our Clinical Validation Center (CVC) is to advance and validate blood-based detection of colorectal advanced adenoma. Blood-based testing, to be maximally effective for colorectal cancer, should have sufficient sensitivity not only for cancer, but also for premalignant lesions, especially advanced adenomas, which are more likely to evolve into cancer. We will collect high quality blood specimens from a large number of subjects with advanced adenoma prior to undergoing polypectomy and serially post- polypectomy as well as from relevant control subjects to evaluate biomarkers for detection of advanced adenoma and for recurrence risk assessment.